Project 4: New Approaches to Improving the Effectiveness of Radionuclide Targeted Treatments in Neuroendocrine Tumors

Neuroendocrine tumors (NETs) are considered an Orphan Disease with a low incidence (<10000/yr) in the United States. Consequently, it has proven very difficult to secure the interest or resources needed to bring newer treatments to the clinical arena for these patients. Although slow to progress in the early stages, once NETs metastasize, the current 5-year survival rate is <30%. Newer, more effective forms of therapy are urgently needed. Targeted radionuclide therapies using single agents such as 131I-metaiodobenzylguanidine (131I MIBG) and 90Y-DOTA-tyr3-Octreotide (90Y-DOTATOC) have shown promise for therapy of small bowel NETs with response rates of 20-40%. Unfortunately, complete responses are notably uncommon, occurring in less than 10% of patients and response duration is often disappointing as well. We propose a Phase I clinical trial combining 90Y-DOTATOC and 131I MIBG that should provide an increase in the radiation dose delivered to tumors without exceeding safe limits for normal kidney and bone marrow. This trial design, based on strong preliminary imaging data and radiation dose modeling, has the potential to provide durable therapeutic benefit for patients with small bowel NETs where other therapeutic strategies fall short. In further basic science studies, we propose an innovative strategy targeting unique G-protein coupled receptor hetero-dimers such as somatostatin receptor/dopamine receptor conjugates that are expressed in NETs. Preliminary data demonstrate that these new targeting agents have high affinity binding to tumor cells; they are predicted to be highly specific for tumor cells as the hetero-dimeric receptors are rarely expressed in normal tissues. Successful development of these unique radionuclide therapies will provide a new paradigm for molecular targeting and image-guided radionuclide therapy that will likely be translated to other malignancies.

Public health relevance
Upon successful completion of the proposed research, we expect to have validated the use of [90Y]DOTATOC + [131I]MIBG in combination as a safe and potentially more effective radiopharmaceutical regimen for treatment of small bowel neuroendocrine tumors (NETs) under Aim 1. We further expect to have identified the key molecular design characteristics of dual-receptor targeted ligands that result in specific, high affinity binding to small bowel NETs in Aim 2. We anticipate that together, these studies will support new radio-therapeutic strategies for patients whose treatment is currently limited to single SSTR2 targeted, radiolabeled peptides. These findings are expected to have an important positive impact because they will provide strong, evidence- based, proof-of-principle for continued development and future clinical trials of dual-receptor, dual-radionuclide therapy for neuroendocrine tumors. This innovative molecular targeting for radionuclide therapy has the potential to provide dramatically improved durable benefit to patients with neuroendocrine tumors for whom no current therapeutic strategy provides adequate disease control.